OpenNeuro: An open archive for analysis and sharing of BRAIN Initiative data

PROJECT SUMMARY/ABSTRACT Data sharing is essential to maximize the contributions of research subjects and the public’s investment in scientific research, but human subjects research also requires strong protection of the privacy and confidentiality of research subjects. This supplement will support an expert in neuroethics to develop a guideline for sharing human neuroimaging data and a data sharing policy for the OpenNeuro project. It will also propose a regulatory safeguard to prevent misuse of data collected or disclosed as part of a research study. This research will promote more responsible sharing of neuroimaging data in the OpenNeuro project and chart a path to protect data privacy without unduly limiting open science practice.

Public health relevance
PROJECT NARRATIVE The sharing of research data is essential to maximize public investments in scientific research, increase public trust, and honor the efforts of human research participants. This supplement will develop a guideline for researchers and those who operate data repositories to navigate complex ethical and regulatory issues in sharing human neuroimaging data and will devise a sound data sharing policy for the OpenNeuro project. A regulatory scheme to prohibit misuse of research data will also be proposed as a safeguard to protect data privacy while maximizing the benefits of data sharing.